Class II artificial antigen presenting cells for cancer immunotherapy

Project Summary
Adoptive cell therapy (ACT) has become an increasingly attractive method for treating
patients with solid tumors due to its impressive response rate; that said, the costs and
complexity of current cellular approaches for expansion of tumor-specific T cells have limited
accessibility of this therapy. Significant progress has been made in scalable, acellular
technologies for expanding tumor-specific CD8 T cells. However, no analogous acellular
platforms for expansion of CD4 T cells exist, despite overwhelming preclinical and clinical
evidence that CD4 T cells are central to antitumor immune responses and can augment CD8-
based therapies. The goal of the proposed project is to investigate the application of a novel
Class II artificial antigen presenting cell (aAPC) for expansion of functional, polyclonal
endogenous tumor-specific CD4 T cells for ACT as well as potential synergies with endogenous
CD8 T cells. The platform, which consists of a 50 nm paramagnetic iron dextran nanoparticle
conjugated with Class II Major Histocompatibility Complex proteins and costimulatory
molecules, will allow us 1) to enrich and expand rare murine and human tumor-specific CD4 T
cells to clinically relevant levels, and 2) to facilitate dendritic cell (DC) independent T cell help. In
turn, the Class II aAPC will allow us for the first time to monitor both the antitumor efficacy and T
cell receptor dynamics of ACT with polyclonal CD4 or combined CD4 and CD8 T cells in mice.
To accomplish these goals, the project will proceed in three phases. First, we will
investigate the in vitro function and in vivo antitumor efficacy of aAPC-expanded polyclonal CD4
T cells specific to foreign and self-antigens, OVA and Trp1 with B16-OVA and B16-F10
melanoma models, respectively. Second, we will apply a modular human Class II aAPC,
capable of expanding a range of antigen-specific CD4 T cells through HLA molecules loaded
with thrombin-cleavable peptides, to expand functional tumor-antigen NY-ESO-1 specific CD4 T
cells from HLA DR1 and DP4 donors. Finally, we will combine the Class I and Class II aAPC
technologies to investigate DC independent in vitro and in vivo antitumor synergies of combined
antigen-specific mouse and human CD4 and CD8 culture, using B16-OVA and B16-F10 for
mouse T cells, and the human SK-MEL-37 (A2+/NY-ESO-1+) melanoma cell line for human T
cells. If successful, this proposal will deliver a novel acellular approach for polyclonal CD4 or
combined CD4 and CD8 ACT and will provide insight into alternative mechanisms of T cell help,
with potential clinical ramifications for ex vivo CD8 T cell expansion.

Public health relevance
Project Narrative The proposed research seeks to apply a novel nanoparticle-based platform for expansion of endogenous polyclonal populations of tumor-specific CD4 T cells for adoptive cell therapy. Through the platform, the proposed research will investigate the antitumor function of antigen- specific polyclonal CD4 or combined CD4 and CD8 T cells targeting foreign versus self-antigens in mouse melanoma adoptive transfer models. The technology will also be adapted to expand human tumor-specific CD4 T cells either alone or in combination with CD8 T cells to observe the functional implications of nanoparticle-based co-activation in vitro and in vivo and to demonstrate the clinical relevance of this technology.